Oligodendrocyte Progenitors and Hyaluronan-mediated Mechanisms of Human Vascular White Matter Injury

Project Summary
Remyelination failure is the hallmark of microvascular white matter injury (WMI) and commonly causes
cognitive impairment and dementia in the elderly. We propose that remyelination failure involves two
complementary mechanisms that generate hyaluronic acid fragments (HAf) that disrupt the maturation of
oligodendrocyte progenitor cells (OPCs). First, we hypothesize that vascular endothelial cells generate HAf in
response to oxidative stress. Second, we hypothesize that vascular injury activates HAf-mediated mechanisms
that promote vascular lumen adhesion and trafficking of lymphocytes to cause white matter inflammation and
reactive astrocytosis to enhance HA/HAf levels. We will focus on human WMI confirmed by ante-mortem MRI-
defined white matter hyperintensities (WMHs). WMHs are the most widely used clinical predictor of risk for
vascular cognitive impairment and dementia (VCID). We will define aberrant HAf-mediated actions related to
cerebrovascular dysfunction in WMHs. We will build upon two recent advances. First, we will undertake
novel vascular physiology studies to define oxidative stress in arterioles isolated from human WMHs.
We showed that WM arterioles from VCID cases selectively displayed reduced endothelium-mediated
vasodilation that predisposes to WMI (Ann Neurol 83:142-152, 2018). Second, we will define aberrant HAf-
mediated mechanisms of myelination failure related to cerebrovascular dysfunction in WMHs. We have
defined a signaling pathway activated by cerebral ischemia where a specific bioactive HAf cell autonomously
blocks OPC maturation to cause myelination failure (J Clin Invest 128:2025-2041, 2018). We will thus utilize
our unique expertise in quantitation and analysis of HA fragments to determine the specific sizes that are
linked to myelination failure in WMHs through mechanisms involving the OPC-vascular niche. In aim 1, we will
employ a combination of molecular and morphometric approaches to test the hypothesis that remyelination
failure in WMHs arises from disrupted HA metabolism that mediates aberrant OPC proliferation and
blocks differentiation to myelinating oligodendrocytes. We will isolate vascular endothelial cell-derived
HAf from WMHs and determine its actions on OPC proliferation and differentiation. In aim 2, we will utilize a
combination of molecular, biochemical and histochemical approaches to test the hypothesis that WM vascular
dysfunction and oxidative/nitrosative stress are linked to altered HA synthesis, catabolism and
signaling in WMHs. In aim 3, we will employ novel murine and human in vitro models to test the hypothesis
that dysfunction of WM arterioles promotes inflammatory mechanisms of myelination failure mediated by
vascular lumen adhesion and trafficking of lymphocytes into WMHs. Our over-riding objective is to provide a
mechanistic molecular explanation for the distinct OPC-vascular processes that render aging human white
matter particularly susceptible to microvascular WMI in order to develop therapies that promote OPC
maturation and mitigate remyelination failure associated with cognitive decline in VCID.

Public health relevance
Project Narrative This proposal focuses on recently discovered mechanisms of impaired regeneration and repair of diffuse human white matter lesions that we propose are central to vascular brain injury and cognitive decline associated with aging and vascular dementia. We will employ pioneering vascular physiology and molecular approaches to define how chronic injury and inflammation of human white matter blood vessels contributes to the progression of white matter injury by studying MRI-defined lesions from human autopsy brains from patients confirmed to have cognitive decline. The role of disrupted white matter blood flow will be related to disrupted maturation of a key brain cell type (the oligodendrocyte progenitor) that appears to play a central role in aberrant brain recovery (remyelination failure) after white matter injury to be defined by MRI.